Regulation of pancreatic ductal adenocarcinoma progression by Hnf4a

Project summary The molecular networks that specify cellular identity and suppress alternative cell fates are tightly regulated during normal tissue homeostasis but can become dramatically dysregulated during cancer progression. It has long been appreciated that tumor differentiation state often correlates with both intrinsic malignant potential and response to therapy. However, the master transcriptional regulators that control cellular identity in most cancer types remain to be elucidated. The long-term goal of this project is to determine how changes in cellular identity contribute to the progression of pancreatic ductal adenocarcinoma (PDAC). Pancreatic neoplasia adopts a foregut-like differentiation state that is distinct from normal pancreatic epithelial cells. We have observed that the differentiation state of pancreatic in situ neoplasia (PanIN) closely resembles that of mucinous lung adenocarcinoma, a type of lung cancer that also exhibits a foregut-like differentiation state. One of the foregut-associated transcripts expressed in both types of neoplasia is Hnf4α, a transcription factor that normally regulates the differentiation state of the gastrointestinal tract and liver. Using conditional murine genetics, we demonstrated that Hnf4α is a critical regulator of the growth and differentiation state of mucinous lung adenocarcinoma. In this proposal, we will test the hypothesis that Hnf4α regulates the differentiation state and malignant progression of pancreatic ductal adenocarcinoma using the following specific aims: (1) Determine the impact of Hnf4α loss on the differentiation and malignant progression of pancreatic ductal adenocarcinoma and (2) Characterize the mechanisms by which Hnf?α regulates the growth and differentiation state of pancreatic ductal adenocarcinoma.

Public health relevance
Project narrative The transcription factor Hnf4 regulates a number of biological processes relevant to cancer progression, including proliferation, differentiation and metabolism. Our preliminary data indicate that Hnf4 plays a crucial role in the initiation of mucinous lung adenocarcinoma. In this project, we aim to determine whether Hnf4 also regulates the initiation and progression of pancreatic ductal adenocarcinoma, a type of cancer that closely resembles mucinous lung adenocarcinoma in its earliest stages.